Enhancement of California's Integrated Food Safety and Security System: Discipline B Track 1

Project Summary/Abstract: Discipline B Chemistry, Track 1 FDA LFFM (U19), FOA PAR-20-105 One primary focus of the Food and Drug Laboratory Branch (FDLB) Chemistry Section is the monitoring of food and drug products to ensure a safe supply for public consumption. The primary objective of the food defense project is to provide surge capacity by expanding the laboratory-testing capability and capacity for toxic chemicals and toxins in human food products by means of food defense surveillance testing, outbreak or incidence investigation testing, and participating in testing requested by FDA for possible chemical threats to food supply and in national and regional security exercises. We propose to maintain and improve national and regional chemical response capacity in the analyses of inorganic and organic contaminants on different food matrices that should cover a variety of food commodities such as fresh produce (vegetables and fruits), manufactured beverages (juice, bottled water, and alcoholic drinks, etc.), milk and related dairy products, baby foods, spices, and seafoods, etc. We will maintain a well-trained staff who are proficient in all the major analytical methods FERN has developed such as the GC-MS / LC-MS for poison / toxin screen (CHE.0006 and CHE.0007), the ICP-MS (EAM 4.7, EAM 4.10, EAM 4.11) for metals and speciation analyses, and other technologies such as XRF and ELISA for faster screening to increase our surge capacity.

Public health relevance
Project Narrative: Discipline B Chemistry, Track 1 FDA LFFM (U19), FOA PAR-20-105 The proposed food defense project that will be performed and maintained within California Department of Public Health, Food and Drug Laboratory Branch will greatly enhance the surge capacity and capabilities of California's human and animal food testing for chemical contaminants in the possible events of intentional or unintentional contamination. The sample matrices should cover a variety of food commodities such as fresh produce (vegetables and fruits), manufactured beverages (juice, bottled water, and alcoholic drinks, etc.), milk and related dairy products, baby foods, spices, and seafoods. The project will employ the following major analytical techniques and methods for the analyses of organic poisons, toxins, preservatives, and toxic metals: HPLC-DAD, LC/MS/MS (FERN CHE.0008), GC/MS (FERN CHE.0006), (LC)-ICP-MS EAM 4.7, 4.11, or EPA 200.8), TXRF, and ELISA.